Molecular Biology and Genetics: Signaling, Epigenetics and Genome Maintenance

The biomedical workforce research needs of our society have increased in size and diversity. We have the
responsibility to help train the next generation of scientists, not only to feed the research needs of academia and
industry, but to train inspiring college science faculty, effective research administrators, science policy makers,
medical writers and scientific editors, business and financial analysts, science consultants, big bioscience data
managers as well as other future essential biomedical research jobs. Thus, our graduates will need to be
equipped with abilities for rigorous critical thinking, develop an interdisciplinary perspective, learn to analyze
complex sets of data, develop complex research approaches utilizing complex equipment while maintaining the
mental flexibility to keep up with the fast pace of biomedical research exploration and application. The overall
goal of this predoctoral program is to offer exceptional interdisciplinary training opportunities in the broad area
of Molecular and Cellular Biology and Genetics with special interest in cell signaling, epigenetics and genome
maintenance. Members of this interdisciplinary program include faculty from the Lewis Katz School of Medicine
(LKSOM), who are mentors in the Cancer Biology and Genetics (CBGN) and the Molecular and Cellular Biosci-
ence (MCBS) concentration clusters. While there are many traditional programs that offer training in each of
these three areas, this program will provide students with the tools and perspectives needed to consider how
these three highly disease-relevant fields intersect.
The focus for this training proposal was chosen primarily to reflect the presence of multiple leaders in these
fields in the CBGN and MCBS clusters. This proposal will support research training opportunities in the labora-
tories of 36 Assistant, Associate and full Professors. Mentors in this program bring strength in multidisciplinary
programs in molecular and cellular biology, biochemistry, biophysics, genetics and epigenetics, using state of
the art approaches in confocal and TIRF microscopy, mass spec proteomics, structural biology, molecular mod-
eling, bioinformatics, high throughput screens, genomics, and epigenomics using a variety of animal and cellular
model systems and human samples. Mentors in this program have a long tradition in the training of both graduate
students and postdoctoral fellows with very high academic standards and will receive additional training in mod-
ern evidence-based mentoring practices. This program will further provide a broader understanding of disease
mechanisms and will develop in the trainees an in-depth understanding of the clinical challenges associated with
their research interest area. Upon graduating, we are confident that this unique interdisciplinary training experi-
ence will make our students not only highly competitive for future positions in academia, industry, science college
education, research administration, science policy and advocacy, technology transfer, science and medical writ-
ing and scientific editing, business and financial analysis, science consulting, big bioscience data managing and
a broader array of future biomedical research jobs.

Public health relevance
The overall goal of this predoctoral program is to offer exceptional interdisciplinary training in Molecular and Cellular Biology and Genetics with a concentration in cell signaling, epigenetics and genome maintenance. This program will provide a broad understanding of disease mechanisms and is aimed at developing in the trainees an in-depth understanding of the clinical challenges associated with their research interest area. Beyond scientific and state-of-the- art technical knowledge and translational research competencies, our goal is to develop in these trainees critical thinking and rigor, managerial, teaching and training skills, communication proficiency and a capacity for professional networking.